Molecular recording to understand the determinants of cell fate transitions in early development

Project Summary
During mammalian development, a single cell gives rise to thousands of diverse and functionally
distinct cell-types. Understanding how each cell-type is determined during development is one of the central
questions in biology with far-reaching consequences for human health and regenerative medicine. While much
of our current understanding of how cell-fate decisions are made is based on either temporally-resolved and
non-destructive methods (e.g., time-lapse microscopy) or high-throughput but destructive genomic assays
(e.g., single-cell RNA-seq), a new method that allows continual observation of each cell throughout the
developmental process will fill the major gaps existing in our understanding of cell-fate transitions during
mammalian development.
Here we propose to develop molecular recording methods that enable the concurrent, non-destructive,
high-throughput measurements of past cellular events and the current cell-type. Our recent methods, DNA
Typewriter and ENGRAM, use precision genome editing to record cell lineage information and key
transcriptional signaling events to the cell’s genome, which are recovered along with the transcriptome at the
single-cell level. During the mentored K99 phase, I will further improve our methods by increasing the lineage
recording efficiency (Aim 1) and testing it in the synthetic mammalian embryo systems (Aim 2). After I
transition to independence in the R00 phase, I will expand the molecular recorder platform to concurrently
capture diverse key cellular events (Aim 3). As our preliminary data on DNA Typewriter and ENGRAM
demonstrate, we are in a strong position to carry out described molecular recording in model development
systems. We anticipate that molecular recording of lineage and key signaling events in the synthetic embryo
systems will deepen our model of early mammalian development. Together, our proposal will serve as a strong
foundation as I transition into my independence and continue developing a general molecular recording
platform.

Public health relevance
Project Narrative The goal of this project is to develop molecular recording methods to record and recover key determinants in cell-fate transitions during early development. We propose to test and optimize our methods in synthetic embryo models that mimic the early mammalian development process. We anticipate that these experiments will deepen the current model of mammalian early development and substantially advance molecular recording technology.